Perivascular tissue models to overcome MGMT-mediated temozolomide resistance in glioblastoma

ABSTRACT
This application is being submitted in response to PA-21-071. Glioblastoma (GBM) is the most common and
lethal form of brain cancer. Standard of care is surgical resection followed by treatment with the alkylating
agent temozolomide (TMZ). Resection removes the tumor bulk, and TMZ provides some benefit to many
patients. The parent Cancer Tissue Engineering Collaborative project (R01 CA256481) is developing tissue
engineering approach to accelerate the evaluation of new anticancer compounds that overcome TMZ
resistance. This project is developing processes to create engineered models of the perivascular niches
(PVNs) that extend from the tumor into the surrounding parenchyma and which are believed to play a dominant
role in invasion, recurrence, TMZ resistance, and poor survival. Conventional bulk hydrogels, even
miniaturized variants, do not provide an avenue to tailor, or trace the evolution of, the local microenvironment
surrounding unique cell subpopulations. The objective of this NCI Diversity Administrative supplement is to
support a novel initiative to create granular hydrogel assemblies that can mimic the multicellular tumor
microenvironment yet are amenable to high-throughput screening approaches conventionally used to examine
drug responses using two-dimensional culture. We have generated the technical foundation to create granular
hydrogel to study GBM therapeutic response. Granular hydrogels are macroscale structures generated as
jammed assemblies of microscale hydrogel particles. To date they have been predominantly used as acellular
hydrogel particles with cells cultured in the voids between particles. As part of a recent administrative
supplement, we developed capacity to encapsulate GBM cells in distinct nanoliter-volume hydrogel
microdroplets that can be rapidly formed, have their matrix composition tailored for discrete cell populations,
and be non-toxically degraded. Now, we seek to expand efforts with granular hydrogel systems to examine
high-throughput response data for glioblastoma cells. To do this, this project will first measure therapeutic
responses of GBM cells to brain-mimetic HA and the perivascular secretome in granular hydrogels (Aim S1).
We will subsequently examine the role of multicellular aggregations on GBM cell invasion and therapeutic
efficacy using both macroscale and granular hydrogel models (Aim S2). This proposed supplement will support
a graduate student from a historically underrepresented group in biomedical research to develop hierarchical
models of the glioblastoma tumor microenvironment. This granular hydrogel approach provides the basis to
interrogate the role of glioblastoma aggregation size and relative spacing on glioblastoma stem cell activity,
GBM invasion, and resistance to frontline therapies. We will show granular hydrogels can be integrated into
high-throughput screening approaches to accelerate the evaluation of novel TMZ derivatives created to target
diffuse GBM cells regardless of MGMT status.

Public health relevance
NARRATIVE Glioblastoma is the most aggressive and deadly form of brain cancer whose poor clinical outcome stems from its diffuse invasion throughout the brain and drug resistance. This project will develop a microdroplet-based tissue engineering approach to create granular hydrogel models of the brain microenvironment to study glioblastoma cell proliferation and drug response.